PHYSIOLOGIC CHARACTERIZATION OF SIV &NORMAL MACAQUE INTESTINAL SEGMENTS

To rigorously examine physiologic alterations that occur during SIV infection we have begun examining intestinal segments in [unreadable]ssing chambers. [unreadable]ssing chambers are the "gold standard" for characterizing the physiology of the intestine in a rigorous, quantitative fashion. In preliminary studies we have examined duodenum, jejunum and ileum in duplicate from five normal, uninfected macaques and seven SIV-infected macaques. We found that duodenal, jejunal and ileal tissues can be harvested from macaques mounted in [unreadable]ssing chambers, and subsequently display extremely consistent, site-specific, transepithelial resistances indicative of healthy, physiologically active intestinal epithelium. Furthermore, duodenal, jejunal and ileal tissues display consistent site-specific responses to the secretagogue theophylline, and to glucose which stimulates absorption. Animals infected with SIV had marked changes in these